Role of hexokinase 3 in macrophage polarization and cardiac remodeling after myocardial infraction.

Project Summary
Myocardial infarction (MI) is a leading cause of death, and macrophages play a critical role in the remodeling of
the heart after MI. Hexokinases (HKs) catalyze glucose phosphorylation, and one HK isoform (HK3) is mostly
expressed in myeloid cells. We have generated global and macrophage-specific (MS)-Hk3-/- mice and have
shown that deletion of Hk3 leads to protection against cardiac ischemic injury and enhances polarization to the
repair M2 subtype with unaltered M1/classical activation. Bone marrow derived macrophages (BMDMs) and
circulating monocytes from mice with Hk3 deletion display increased glutathione levels and NRF2 activity; also,
acute inactivation of HK3 leads to increased reactive oxygen species (ROS). These results suggest that HK3
plays a major role in macrophage polarization and that its deletion increases macrophage repair phenotype,
NRF2 activation and glutathione production, and protects against ischemic injury. In this proposal, we will
address the fundamental gap in knowledge of the role of macrophages and their metabolic processes in
cardiac remodeling after ischemia/reperfusion (I/R). Our central hypothesis is that HK3 plays a major
role in macrophage polarization, such that its deletion results in polarization towards the repair
phenotype and an improvement in cardiac remodeling after I/R. We also propose that the mechanism for
the M2 polarization with Hk3 deletion is through NRF2 activation and glutathione production. In Aim 1,
we will determine whether HK3 restrains NRF2, so that when it is deleted, NRF2 gets activated leading to
glutathione synthesis. We also hypothesize that the mechanism for NRF2 activation is through an initial increase
in ROS production. We will obtain cells at early and late timepoints after Hk3 deletion by crossing Hk3f/f mice with
CX3CR1-CRE-ERT2 and assess: 1) ROS levels, 2) NADPH levels, 3) NRF2 activation, 4) glutathione
production, and 5) glucose carbon tracing. We will also assess whether antioxidants reverse NRF2 activation
and glutathione production. In Aim 2, we will determine whether deletion of Hk3 drives macrophage polarization
through the transcriptional or metabolic effects of NRF2. We will first cross MS-Hk3-/- with Nrf2-/- mice and assess
M2 polarization. We will also test whether Hk3 deletion drives macrophage polarization through direct
transcriptional activation of M2 genes by performing RNA-Seq and ChIP-Seq. Finally, we will test whether the
effects of NRF2 on glutathione or its antioxidant effects mediate the macrophage polarization induced by Hk3
deletion by measuring polarization of macrophages in MS-Keap1-/- mice (constitutively active NRF2) or with
buthionine sulfoximine (BSO, an inhibitor of glutathione production) or ROS inducers. In Aim 3, we will determine
whether Hk3 deletion protects against I/R through improved cardiac remodeling and will identify the cell
populations that exert this protective effect. We will subject Hk3-/-, MS-Hk3-/, and mice with neutrophil-specific
Hk3 deletion to I/R, followed by measurement of cardiac function and remodeling markers. We will also assess
the role of cardiac-resident and tissue macrophages that originate from circulating monocytes in this process.

Public health relevance
Project narrative Myocardial infarction (MI) is a leading causes of death in the world, and macrophages play a critical role in the remodeling of the heart after MI. Hexokinases (HK) catalyze the first step in glucose metabolism by phosphorylating glucose, and one HK isoform (HK3) is predominantly expressed in macrophages. In this proposal, we will assess whether HK3 plays a role in macrophage polarization and the mechanism for this process, and will determine whether deletion of HK3 is protective against cardiac damage after MI.